Intervention Strategies for Non-Folate Responsive Neural Tube Defects

ABSTRACT
Congenital defects are the leading cause of neonatal mortality, resulting in more infant deaths than the combined
adult death tolls of Alzheimer’s disease, strokes, diabetes, and influenza. Neural tube defects (NTDs), the second
most common category of human birth defects, arise when the neural tube fails to close properly during
neurulation. Globally, these defects are estimated to affect approximately 18.6 per 10,000 live births and the
prevalence of NTDs is 1–2 per 1,000 births in most regions of the US. There are approximately 2,300 NTD-
affected pregnancies in the US each year, whose lifetime medical costs are estimated to be $560,000 per child
or $1.68 billion per year nationwide. Despite intensive investigation for decades, relatively little is known about
the underlying NTD risk factors. It is generally accepted that NTDs are of a multi-factorial origin, having both
environmental and genetic factors that contribute to the malformation. Although it is established that
periconceptional use of folic acid (FA) prevents a significant percentage of the population burden of NTDs, the
mechanisms underlying those processes by which FA reduces NTD risk remains unknown. Importantly, there
are significant numbers of NTDs that are not preventable by FA supplementation, with these FA-resistant NTDs
occurring at an apparent baseline rate of 5 per 10,000 live births. Thus, NTDs remain a substantial public health
problem, and there is a critical need to understand the mechanisms underlying FA-resistant NTDs and to
develop novel intervention strategies targeting this population
To expand upon work performed in the initial funding period, our proposed line of study explores mechanisms
by which impairment of mitochondrial one carbon metabolism causes NTDs and how our proposed interventions
successfully restore proper NTC. Simultaneously, we are testing the efficacy and investigating mechanisms by
which glycine supplementation rescues these FA-resistant defects. Establishing these mechanisms and relating
them to actual human NTD variants may eventually allow us to utilize our proposed intervention strategies to
prevent previously unpreventable birth defects by informing public health policy or precision medicine strategies,
thus reducing the significant negative health burden of these debilitating defects on affected families and the
public.

Public health relevance
PROJECT NARRATIVE Folic acid (FA) supplementation is an effective modifier of neural tube defect (NTDs) prevalence, although a significant proportion of NTD cases are FA resistant. We hypothesize that some FA-resistant NTDs may be prevented by intervention with glycine. Discerning the mechanisms underlying the beneficial effects and relating them to known human NTD gene variants may enable us to expand effective intervention strategies to prevent previously unpreventable NTDs.